Training verbal mediation to support executive function in children with developmental language disorder

PROJECT ABSTRACT
The complex and unclear relationship between language and executive function (EF) creates barriers to
developing effective interventions for children with developmental language disorder (DLD) whose language
difficulties often co-occur with impaired EF. Children and adults with typical language development (TD) facilitate
their EF by using self-directed language, or verbal mediation, to guide conscious reflection and override habitual
behaviors. Conversely, children with DLD do not use verbal mediation to support EF efficiently or effectively.
Promising evidence suggests that language-based training can shape verbal mediation and improve EF task
performance in children with TD, which makes it pertinent to determine whether verbal mediation training benefits
children with DLD. Specifically, modeling interventions have been shown to promote learning of language forms
without taxing the cognitive resources required for learning such as attention or working memory, which are
known to be impaired among children with DLD. The long-term goal of the proposed work is to optimize
intervention outcomes for children with DLD by elucidating the complex relationship between language and
executive functions. The objective of this project is to determine the impact of modeling verbal mediation on
shifting task performance in school-aged children with DLD. Shifting, also known as cognitive flexibility, is the
ability to alternate between operations or mental sets. It is an important EF because it is the pivot point between
multiple goal-directed tasks when language use is critical for guiding action. Children aged 8-10 years will
complete three versions of a shifting task over three phases: pre-intervention, intervention, and post-intervention.
During the intervention phase, half of the participants with DLD will be exposed to a task model with verbal
mediation (training), while the other half will be exposed to a silent task model (control). We will determine the
effect of modeling verbal mediation on the subsequent use of verbal mediation (Aim 1) and behavioral and
electrophysiological measures of shifting ability (Aim 2). We will supplement indirect measures of shifting (i.e.,
accuracy and reaction time) with an electrophysiological marker of shifting that reflects real-time cue processing.
This combination of methods provides insight to changes in processing following intervention that may precede
and predict subsequent changes in behaviors. Our central hypothesis is that modeling verbal mediation will
facilitate more effective use of verbal mediation and improve shift cue processing in children with DLD. The
project will provide a theoretical framework for the role of language in shaping goal-directed behavior and the
first examination of electrophysiological change in shifting following a verbal mediation intervention. Results will
have a significant impact on clinical practice by advancing knowledge about a promising language-based
intervention to support EF and other goal-directed tasks.

Public health relevance
PROJECT NARRATIVE Developmental language disorder (DLD) is a highly prevalent impairment in the use and understanding of language that negatively impacts many other cognitive and academic skills, including verbal mediation or the use of self-directed language to guide task performance. This project will determine the impact of an intervention that models verbal mediation during an executive shifting task on (1) the subsequent use of verbal mediation and (2) behavioral and electrophysiological measures of shifting ability in school-aged children with DLD. Results will enhance public health by showing how children with DLD can use language to support executive function and other goal-directed tasks.